Compensatory Mitochondrial Protective Mechanisms Against Oxidative Stress in PD

Abstract
The complex and prolonged disease course exhibited by Parkinson’s disease (PD) first starts with non-motor
disturbances and then slowly progresses to mild-to-moderate motor deficits, ultimately inflicting severe motor
and cognitive deficits. Although pathophysiological mechanisms underlying various stages of the disease have
yet to be characterized, both mitochondrial dysfunction (MD) and neural oxidative stress (OS) have been
identified as key pathological correlates in the progressive neurodegenerative process in PD. While studying key
oxidative signaling mechanisms that regulate susceptibility of the nigrostriatal dopamin(DA)ergic system to MD
and oxidative damage, we unexpectedly discovered that protein kinase D1 (PKD1) is highly expressed in nigral
DAergic neurons and that the kinase is rapidly activated during the early stages of oxidative insult to protect
DAergic neurons against oxidative damage. Our mechanistic studies revealed that activated PKD1 rapidly
translocates to both mitochondria and the nucleus of DAergic neurons. Our preliminary studies show that
activated PKD1 likely enhances the transcription of key neuro-adaptive oxidative mechanisms involving
enhanced PGC1-α, TFAM and BDNF signaling pathways. Thus, the goal of this study is to elucidate
mitochondrial/nuclear events governing the PKD1-mediated compensatory protective response using cell and
animal models of PD. The overarching hypothesis of our proposal is that the pro-survival kinase PKD1 is rapidly
activated in nigral DAergic neurons during the initial stage of an oxidative insult and quickly translocates to
mitochondria and nuclei to initiate cell survival signaling pathways. Its nuclear translocation initiates key pro-
survival transcriptional machinery responsible for PGC1-α, TFAM and BDNF upregulation, leading to enhanced
mitochondrial biogenesis and neurotrophic support in DAergic neurons. Mitochondrial translocation of PKD1
improves mitochondrial function by regulating mitochondrial quality control (MQC). Thus, PKD1 serves as a key
‘compensatory adaptive switch’ in nigral DAergic neurons. To test this, we will systematically pursue the following
specific aims: (i) characterize PKD1 activation and nuclear/mitochondrial translocation and its functional
relevance in cell culture and animal models of PD; (ii) characterize the downstream pro-survival signaling
pathways activated by PKD1 mitochondrial/nuclear translocation in DAergic neurons; and (iii) validate PKD1 as
a therapeutic target of PD and examine the translational potential of a novel PKD1 activator. We will use multiple
model systems and state-of-the-art cellular, histological and neurochemical approaches to achieve these specific
aims. Our multifaceted approach to harness the PKD1 adaptive signaling mechanisms that promote DAergic
neuronal survival will enable us to devise a novel translational strategy capable of intervening early in the course
of disease progression in PD.

Public health relevance
Narrative Parkinson’s disease (PD) is an incurable neurodegenerative disorder (ND) affecting over a million Americans but no effective treatment options are available to slow down the progression of the disease mainly due to the lack of an in-depth mechanistic understanding of the complex neurodegenerative processes underlying the disease. The research proposed here will identify a novel protective mitochondrial and nuclear subcellular signaling network mediated by protein kinase D1 activation, which is inherent in dopaminergic neurons during the early stages of neuronal oxidative stress (OS). The outcome of this research program will help devise a new treatment strategy that can intervene early in the progression of this debilitating disease.